A Chemosensory-Mechanotransduction System Regulating Ventricular Size and Brain Function

Parent Grant Summary/Abstract
How the brain determines cerebral ventricular volume, and how that in turn affects brain function, are
poorly understood. In patients who develop idiopathic normal pressure hydrocephalus (iNPH) or low pressure
hydrocephalus after intracranial hemorrhage, infection or other brain insults, ventricular volume increases in the
absence of obstruction to cerebrospinal fluid (CSF) flow, sustained intracranial pressure (ICP) elevations or brain
atrophy. iNPH patients display motor apraxia, dementia and incontinence that are often improved by CSF
drainage, but the underlying mechanisms are not known. Numerous studies suggest that ependymal motile cilia
dysfunction somehow leads to hydrocephalus, albeit via unclear mechanisms. Indeed, some investigators have
challenged this notion, suggesting instead that increased CSF production, decreased CSF absorption, or
abnormal brain development are responsible. Here we present evidence for an ependymal chemosensory-
mechanotransduction system that uses motile cilia to convert chemical signals to changes in flow that govern
ependymal cell junction assembly, ventricular wall stiffness and ependymal permeability. By controlling
ventricular compliance and the exchange of CSF between the ventricular and interstitial spaces, this system
regulates ventricular volume, the relative distribution and composition of fluid in the ventricular and interstitial
compartments, and neuronal activity, all without altering ICP. To elucidate why ventriculomegaly and
neurological deficits develop in iNPH, we sequenced DNA from iNPH patients to identify iNPH-associated
mutations. Most of the iNPH-associated mutations involved genes that encode proteins associated with cilia,
and all of the genes showed increased expression in ependymal or choroid plexus cells. iNPH-associated
mutations affecting CWH43 or AK9 occurred in 25% of iNPH patients. Mice harboring iNPH-associated CWH43
or AK9 mutations displayed decreased motile cilia number or motility, respectively, and developed
ventriculomegaly and gait imbalance characteristic of iNPH. We now show that the ventriculomegaly is
accompanied by normal ICP, increased ventricular compliance and permeability, and disassembly of ependymal
cell junctions. We and others have discovered multiple receptors that localize to ependymal motile cilia and
regulate CSF flow by modulating cilia beat frequency. Mutation of these receptors increases ventricular volume.
In normal mice, we find that flow is required to maintain ependymal cell junctions. This process involves activation
of ependymal Piezo1, TRPV4, and PKD2 mechanotransduction channels. Induced conditional deletion of Piezo1
or PKD2 in adult mice increases ventricular size. We observed a diurnal increase in ependymal permeability that
increases exchange between ventricular CSF and interstitial fluid during sleep. We find that ventriculomegaly in
CWH43 or AK9 mutant mice is associated with a task-dependent decrease in neuronal activation in the
hippocampus and parietal cortex that may underlie the dementia and motor apraxia of iNPH. We will examine
how this ependymal chemosensory-mechanotransduction system regulates ventricular size and brain function.

Public health relevance
Parent Grant Narrative How the brain determines cerebral ventricular volume, and how that in turn affects brain function or the development of normal pressure hydrocephalus, are poorly understood. This proposal will investigate our discovery of an ependymal chemosensory-mechanotransduction system that uses motile cilia to convert chemical signals into changes in flow which govern ependymal cell junction assembly, ventricular wall stiffness and ependymal permeability. By controlling ventricular compliance and the exchange of CSF between the ventricular and interstitial spaces, this system regulates ventricular volume, the relative distribution and composition of fluid in the ventricular and interstitial compartments, and neuronal activity in brain regions that subserve memory and motor functions.